THERAPEUTIC MASSAGE AND PHYSIOACOUSTIC VIBRATIONS: SURGICAL OUTCOMES

This comparative study is evaluating the efficacy of postoperative massage and physioacoustic vibrations in improving outcomes for patients undergoing abdominal laparotomy for removal of malignant lesions. Primary outcomes include: patient sensory and affective pain ratings, anxiety and distress levels. Secondary outcomes include: urinary cortisol levels, NK cell activity, systolic BP, pulse, number of additional health services. GCRC will be utilized for cortisol assay and blood preparation.